GROWTH HORMONE IMPROVES THE CLINICAL STATUS OF MALNOURISHED CF PATIENTS

Malnutrition affects over one third of patients with cystic fibrosis (CF), and has been directly linked to increased morbidity and mortality. Human recombinant growth hormone (GH) has proven effective for treatment of malnutrition in AIDS and other chronic illnesses. The hypothesis of this study is the anabolic effects of GH will reverse protein malnutrition and improve the nutritional and clinical status of malnourished CF patients. This randomized study will treat 10 malnourished CF patients with GH compared to 10 CF control patients. To date, 11 children have been enrolled (6 treated with growth hormone, and 5 untreated). Each has completed 3 months of the study. To date, investigators have found that the patients taking growth hormone have increased body weight, fewer infections, and increased pulmonary function. Further analysis will be done at 6 months.